BIOMOLECULAR STRUCTURE AND INTERACTIONS

The goal of this research is to determine the principles that underlie the interactions of key biological molecules. To do this, we will use the methods of x-ray crystallography to determine the three dimensional structures of selected systems. We are studying molecular complexes involved in the activation of transcription in E coli: DNA, the catabolite gene activator protein, and the alpha subunit of RNA polymerase. We are also studying RNA protein complexes that are involved in the influenza A infection. In addition, we are determining the structures of selected oligonucleotides in an attempt to understand the effects of sequence and environment on DNA structure.